Statistical disease modeling and clinimetrics to prepare for preventive trials in huntington disease

Project Summary
Huntington disease (HD) is a fatal, costly, autosomal dominant neurodegenerative disease with no available
disease-modifying treatments. While genetic testing can identify the presence of the mutant HTT gene, there
are no markers to document the initiation of pathological changes or demarcate when preventive interventions
are optimal to maximize quality of life. While clinical trials to slow progression and delay or prevent onset are
beginning, methods to assess their efficacy are lacking. The proposed research will fill these gaps in our ability
to design preventive clinical trials for HD. First, we will use the legacy PREDICT data to develop statistical
models of onset, progression rate and phenotypic heterogeneity and then we will recruit 250 participants to
complete the field's best Clinical Outcome Assessments (COAs) for premanifest HD and subject them to
clinimetric tests of reliability, validity and responsiveness so future preventive trialists can utilize the information
to design well-powered and efficient trials to delay the onset or slow the progression of HD

Public health relevance
Project Narrative HD is a fatal, genetic, neurodegenerative disease for which there are no disease-modifying treatments. Whereas clinical trials to slow the progression or delay the onset of this disease are underway, there are no ways to determine who should be enrolled or how we can determine that a treatment is being effective in premanifest HD. The proposed research is designed to answer these critical questions so that clinical trials to delay the age of onset or slow the progression of disease can begin at the right time and so we will know if they are doing as we had hoped.